A pilot study of cross-cutting e-health prevention approaches to address campus sexual assault and alcohol misuse

Project Summary
Sexual violence (SV) and alcohol misuse are critical and interconnected problems among college students.
Over 75% of campus sexual assaults involve alcohol, which has been associated with more violent assault
incidents, increased self-blame, and decreased help-seeking among survivors. The college campus culture
presents unique challenges at both the individual, relationship and community levels of the social ecological
model to effectively reduce these destructive behaviors. Several e-health SV, alcohol misuse, and bystander
interventions have been tested previously for efficacy and independently are associated with reductions in SV
and binge drinking, as well as increases in bystander behaviors among college samples. However, most of
these remain at the individual level of the social ecological model and are delivered independently. A
comprehensive approach with preventive interventions at multiple levels of the social ecological model (i.e.,
individual, relationship, and community) is critical to having a population-level impact on SV and alcohol
misuse. However, a comprehensive approach to SV and alcohol misuse has not been implemented or tested.
The proposed research 3-Year AREA Pilot Study fills a major gap in SV and alcohol misuse prevention on
college campuses by implementing and testing the feasibility of a multi-level approach consisting of six
established e-health primary prevention strategies. The proposed three-phase study is innovative in that it will
be the first to (1) implement a Cross Cutting e-health Prevention Program (CCePP), with six evidence-based
and proven alcohol misuse and SV prevention strategies as a full package of synergistic cross-cutting
interventions that target multiple levels of the social ecological model (individual, relationship, and community);
and (2) asses acceptability, demand, implementation, and preliminary efficacy of the CCePP in affecting
multiple cross-cutting primary and secondary outcomes. Undergraduate student researchers (URAs) will be
engaged in all aspects of the proposed research. The proposed research will be implemented in three phases:
Phase 1 will involve conducting two sets of focus groups to update and finalize messaging and dissemination
for two of the e-health interventions including a social marketing campaign and social media campaign and the
administration of a survey to conduct a norms documentation for an individual level e-health intervention;
Phase 2 will involve implementing a mixed-design pilot study that includes both a randomized controlled trial
and a quasi-experiment for testing the CCePP over the course of one semester to assess the acceptability,
demand, implementation, and preliminary efficacy of the CCePP; and Phase 3 will involve interviews with
campus stakeholders and Student Advisory Board members to examine implementation factors related to
adoption and dissemination of CCePP across college in the U.S. These activities will support colleges in the
adoption and sustainment of CCePP, with the goal of reducing the research-to-practice pipeline gap, and future
research testing the effectiveness of implementation strategies.
8. Project

Public health relevance
Project Narrative Sexual violence (SV) and alcohol misuse are critical and interconnected problems among college students. Yet, despite the proliferation of evidence-based sexual violence and alcohol misuse programs for colleges, there has been no effort to integrate these programs to provide a comprehensive approach to reducing SV and alcohol misuse, therefore it is crucial to implement and evaluate comprehensive prevention programs that address this significant public health problem impacting young adults ages 18-24. The proposed R15 AREA research study fills a major gap in SV and alcohol misuse prevention on college campuses by implementing and testing the feasibility of a multi-level social ecological model (e.g., individual, relationship, community) approach consisting of six established e-health primary prevention strategies in a three-phase study that includes formative evaluation (N=870), a feasibility study (N=350) and implementation science interviews (N=15 participants from the Student Advisory Board and N=15 campus stakeholders).